Application of Statistical Methods in Epidemiology Studies

In collaboration with Dr. Alexandra White’s group in the Epidemiology Branch, we are exploring exposome data analysis with the Sister Study data. Our group supported the statistical analysis for Dr. Kelly Ferguson’s group (EB), to identify the distinct growth patterns within the SGA and LGA births. Our group provides statistical mentorship and support for Dr. Mandy Goldberg’s K99/R00 project on “Minipuberty of infancy: a critical period for growth and development in girls?” We are also in collaboration with Dr. Leping Li (BCBB) on analyzing electroencephalogram (EEG) data collected during sleep.